Application for cooperative agreement funding to implement FSMA Preventive Controls for Human Foods

VERMONT DEPARTMENT OF HEALTH - FOOD AND LODGING PROGRAM Expansion Supplement to Implement FSMA Preventive Controls for Human Food Vermont is a small New England state with a population of approximately 620,000 people. The Vermont food landscape is diverse, with many producers and processors of local products from farm to table. The Vermont Department of Health (VDH) is the state’s lead agency for public health policy and advocacy. State regulatory jurisdiction over food producers is shared between the Vermont Department of Health (VDH) and the Vermont Agency of Agriculture, Food and Markets (VAAFM). In 2008, VDH enrolled in the Manufactured Food Regulatory Program Standards (MFRPS). Since 2012, MFRPS cooperative agreement funding has been vital for achieving implementation and conformance with the standards, and has improved the quality and resources of the overall food safety program. VDH is proposing cooperative agreement funding to support program personnel and IT resources for implementing a FSMA Preventive Controls for Human Food (PCHF) inspection and compliance program. This includes proposed funding to support technical staff dedicated to implementing rulemaking, inspection module development, compliance programs, increased environmental sampling, and increased workplanning with FDA. Training funds will continue to allow inspection staff to participate in FDA training courses, including regulator training for Preventive Control rule implementation. The cooperative agreement funding will support dedicating significant resources to implementing this PCHF program in the state. 1

Public health relevance
FSMA Preventive Controls for Human Foods (PCHF) Implementation Expansion Supplement Project Narrative The Vermont Department of Health (VDH) is applying for Flexible Funding Model cooperative agreement expansion supplement funding to support resources required to implement a FMSA Preventive Controls for Human Food program in Vermont. The overall goal of improving food safety and protection of public health from farm to table in Vermont. The mission of VDH is “To protect and promote optimal health for all Vermonters.” There is a public health need to continue improvements in regulatory program activities, training, resources, and infrastructure based on the current science and federal regulatory requirements. Increasing local food production in Vermont is seen as an ideal way to grow local businesses and create local jobs, which has increased the number of food processors and local food products available for national distribution. Funding for implementing a PCHF state inspection program will support increased alignment, communication, and consistency between VDH and FDA to address emerging food safety needs for Vermont producers and processors to protect public health.